Novel carriers for enhanced oligonucleotide permeability through the blood-brain barrier

ABSTRACT
Unmet need: As reported by the World Health Organization, more than 3 billion people worldwide lived with a
neurological condition in 2021. The disability, illness, and premature death caused by neurological conditions
have increased by 18% since 1990, and the economic burden is $800 billion annually in the United States. The
blood-brain barrier (BBB) prevents many molecular formulations that could alleviate these conditions from
reaching the nervous system, rendering them ineffective. Oligonucleotide (ON) therapeutics have received FDA
approval for several genetic diseases outside the CNS; Unlike treatments that merely mitigate symptoms, ONs
can target and reverse the underlying molecular dysfunction. Zippin Bio introduces "ZippinCarriers," a
groundbreaking delivery platform designed to transport ONs and other BBB-impenetrable molecules to the brain.
ZippinCarriers are ultrasmall nanoparticles (<2nm) that connect a plasma protein transferrin to ON and enable
ON CNS transport through a receptor-mediated pathway. A key advantage of ZippinCarriers is high adaptable
physicochemical properties, allowing them to accommodate diverse payloads and improve cellular uptake.
Unlike the current anti-transferrin receptor ligands used in CNS-targeted ON therapies, ZippinCarriers resist
aggregation and offer scalable advantages.
Aims and Methods: Our goal in this Phase I project is, to evaluate ZippinCarriers for their ability to deliver
phosphorodiamidate morpholino oligomers (PMOs) to the CNS. Our overarching goal is to incorporate
ZippinCarriers into PMOs to facilitate BBB passage via transferrin receptors and improve brain penetration and
cell uptake. Our specific aims for Phase I are: SA1. Create a library of eight ZippinCarriers with varying sizes,
shapes, charges, compositions, and hydrophobicity, then conjugate them to PMO and transferrin, SA2. Screen
the ability of eight ZippinCarrier-PMO conjugates to cross the BBB in vitro using three-dimensional (3D)-BBB
models in microfluidic systems, SA3. Evaluate the best-performing four conjugates in the brain of C57BL/6 mice.
Our metric for Phase I is to find a ZippinCarrier to specifically cross the BBB with consistent data in vitro and in
vivo. Success in these areas will set the stage for Phase II, where we will conduct comprehensive efficacy and
safety studies in healthy and diseased animal models and optimize a scalable manufacturing process using
continuous flow systems at the Corvallis Microfluidics Technology Hub.
Innovation and Impact: ZippinCarriers are a breakthrough in brain drug delivery with an ultrasmall size,
scalable, specific, and minimally invasive solution. With 70+ years of collective expertise in organic and inorganic
chemistry, drug delivery, and entrepreneurship, our platform technology addresses the urgent need for effective
CNS delivery of PMOs that opens the door for broader applications in ON therapeutics, potentially reshaping the
landscape of treatment for genetic and rare CNS diseases.

Public health relevance
Project Narrative. This project addresses the critical challenge of delivering gene therapies across the blood-brain barrier (BBB), a major hurdle in treating central nervous system (CNS) disorders. By developing novel drug carriers that enhance cellular uptake and BBB penetration, this innovation promises to improve treating CNS diseases. The successful implementation of this technology could lead to more effective and accessible therapies for a wide range of CNS conditions, ultimately reducing the burden of these diseases on public health and improving the quality of life for millions of patients.